Administrative Core

ADMINISTRATIVE CORE
ABSTRACT:
The Yale Diabetes Research Center (DRC) was established in 1993 with the goal of promoting research in
diabetes and related metabolic and endocrine disorders at the University. The DRC brings together a
multidisciplinary group of more than 100 member and associate member scientists as well as professional
supporting staff, new investigators and research trainees from in 16 departments and 4 colleges or schools at
Yale University The scope of the research activities of the membership is very broad, ranging from basic
molecular biology to whole body physiology and the treatment of diabetic patients. The members, however,
share a common interest in research that is related to diabetes and disorders of metabolism or is fundamental
to understanding its pathogenesis or for the development of new treatment strategies. The design of the Yale
DRC is aimed at developing an infrastructure that could serve as a catalyst to stimulate innovative diabetes and
metabolic-related research. The cornerstone of the DRC is its five Research Cores that provide funded basic
and clinical investigators with the opportunity to more efficiently utilize resources and expand the scope of their
research programs. The Metabolism and the Diabetes Translational Cores facilitate metabolic research in
patients, whereas the Molecular Genetic Mouse Core, Physiology and Cell Biology Cores that comprise the more
basic science focus of the Center offer investigators the tools to create and test novel animal models starting
from the molecule and ending with biological outcomes. The Administrative Core oversees the operation of the
Center, its Pilot/Feasibility Project and Enrichment Programs, and helps to coordinate patient-based research in
diabetes. The goals of the DRC are to: 1) stimulate multidisciplinary interactions, particularly between basic and
clinical scientists; 2) encourage established investigators not presently working in diabetes-related areas, to
bring their expertise to bear on problems relevant to diabetes and metabolism; 3) efficiently organize time
consuming and/or costly techniques through Core facilities to enhance the productivity of investigators
conducting research in diabetes related areas; 4) promote new research programs through pilot feasibility
projects; 5) enhance the quality of research training of future DRC members, and 6) create a stimulating
institutional environment that enhances research efforts by its members to develop new strategies to prevent
and treat diabetes and related metabolic disorders at the local and national level. Thus, the Yale DRC provides
the infrastructure to support a wide spectrum of clinical and basic scientists who are working collaboratively
understand why diabetes develops, and to translate discoveries from the bench to the bedside and ultimately to
create new strategies for the prevention and treatment of patients with, or who are at risk for developing diabetes.
The principle functions of the Administrative Core (Admin Core) are:
A. Administrative and Financial Management
B. Provision of Research Support Services
C. Administration of the Pilot and Feasibility Project Program
D. Provision of a Scientific Enrichment Program